Administrative Core

Administrative Core Summary
The Administrative Core will provide leadership and direction to enable the KY INBRE network to grow
in a purposeful and managed way. The Administrative Core will provide oversight of the Developmental
Research Project Program and Data Science Core and coordinate the activities of the governance committees
and overall network. In addition to this global management of the network, the specific duties of the
Administrative Core will include management of programs to engage students in research, recruit faculty with
biomedical research experience, provide promising early career scientists with mentored research experiences,
develop curricula that includes research, and provide infrastructure support to the network. Specific duties of
the Administrative Core also include management of the budget, development of predictive financial plans, and
tracking and reporting outcomes. In the next funding cycle, the Administrative Core will work with the other KY
INBRE components to continue to build research capacity and develop a strong biomedical research workforce
in KY. We propose to accomplish these goals via the following specific aims: (1) provide research experiences
for students; (2) promote curriculum development in KY institutions; (3) recruit faculty with biomedical research
training and mentor early career scientists; (4) provide sound management of KY INBRE funds and ensure
financial support of PUIs; and (5) evaluate the KY INBRE program and report outcomes.